Investigating the mechanism of Ess1-mediated regulation of the CTD of RNAP II phase separation

Project Summary
The intrinsically disordered carboxy terminal domain (CTD) of RNA polymerase II (RNAPII) may
nucleate the formation of transcription factories through a mechanism of liquid-liquid phase separation
(LLPS). Transcription factories are densely packed membraneless organelles (MLOs) that contain all
the necessary components to perform the transcription cycle. The intrinsically disordered carboxy
terminal domain (CTD) of RNA polymerase II (RNAPII) in model organisms such as S. cerevisiae, S.
pombe and C. albicans, is composed of ~ 26 copies of consensus repeats (Y1S2P3T4S5P6S7). However,
we have recently shown that CTD sequences of fungi isolated from geographically distinct locations
from temperate to polar regions, show high sequence diversity at positions 1, 4, and 7 and undergo
LLPS differently. The CTD is highly conserved at its Ser-Pro motifs where it is the target of
phosphorylation and cis-trans prolyl isomerization by Ess1. Ess1, an essential PPIase in yeast (Pin1 in
humans), has a highly conserved evolutionary relationship with the CTD. Ess1 and phosphorylation
may modulate the phase separation behavior of the CTD, but the molecular mechanism remains
elusive. This proposal has two specific aims to test my hypothesis. In Aim 1 we will elucidate the
mechanism of CTD LLPS by generating wild-type CTD and functional unit mutants and subjecting them
to a series of turbidity assays with and without the presence of Ess1 to elucidate differences in LLPS
due to sequence contribution. LLPS will be observed by naked eye, differential interference (DIC)
microscopy, dynamic light scattering (DLS) and UV-Vis spectroscopy. In Aim 2 we will determine how
regulators of CTD function, phosphorylation and isomerization by Ess1, influence the LLPS of the CTD.
To do so we will adopt the same approach as Aim 1 but phosphorylate CTD constructs and induce the
LLPS of these constructs with and without the presence of Ess1. For both aims 1 and 2 we will
investigate the atomic structure of the CTD both phosphorylated and non-phosphorylated and in
complex with Ess1. We will utilize nuclear magnetic resonance spectroscopy (NMR) and specialized
pulse sequences that enable the detection of single amino acid residues to determine the isomerization
state of the CTD which will enable the elucidation of Ess1 involvement in LLPS. Upon completion of
this study, our expected outcomes are elucidation of the mechanism by which LLPS of the CTD recruits
Ess1 and how cis-trans isomerization influences LLPS. We expect to have a positive impact by
providing a molecular basis for the role of LLPS in mediating the assembly of transcription factories by
the CTD, thereby enabling additional pathways for therapeutically targeting transcription associated
diseases.

Public health relevance
Project Narrative The assembly and disassembly of CTD-mediated transcription factory and the molecular interactions that regulate this process are poorly understood. Dysregulation of transcription is associated with cancer, diabetes, obesity, autoimmunity, neurological disorders, and cardiovascular diseases. In this proposal, I will focus on two regulators of transcription; phosphorylation of CTD from fungi living in extreme environment and their cis-trans prolyl isomerization by the PPIase Ess1, and how these modifications influence the LLPS of the CTD in vitro and at the atomic level.